AACR Conference on The Science of Cancer Health Disparities

The proposed conference series, titled “The Science of Cancer Health Disparities,” will be held annually in the fall (2024-2028). The locations of the 2024-2028 conferences remain to be selected but will be chosen based on several factors including proximity to communities impacted by cancer disparities as well as the future needs and growth of the conference series. This proposed conference series will be the 17th-21st in an AACR series focused specifically on the science of cancer health disparities. The first conference on The Science of Cancer Health Disparities was held in 2007, then annually from 2009-present. While many conferences on cancer health disparities focus on policy and public health issues or one specific population, the goal of this conference is to feature the full spectrum of research in the field and incorporate presentations on a range of populations while including perspectives from basic, population, behavioral, computational, translational, and clinical researchers in conjunction with those from patient advocates, government, public health experts, and others. Interdisciplinary interactions and collaborations will be pivotal to advancing the field, stimulating new research, and making progress in reducing and ultimately eradicating cancer health disparities. Additionally, this conference series serves as a platform to facilitate the development of a cancer workforce from a broad range of backgrounds and to provide educational opportunities to clinicians treating a variety of patients. Professional development opportunities for early career investigators are available at all levels of the conference from experience as session chairs and program committee members to poster presentations and mentored roundtable discussions. CME credits are available for clinicians seeking to increase their knowledge and skills in providing treatment to a broader range of patients.

Public health relevance
Analysis of cancer incidence and mortality data underscores the disproportionate impact of cancer between various groups. These disparities arise from a complex interplay of several elements including socioeconomic, logistical, biological, and genetic factors. This conference series serves as a platform for bringing together basic scientists, physicians, behavioral researchers, population scientists, healthcare experts, and members of the community to encourage interdisciplinary collaborations, foster the development of a cancer workforce that reflects a broad range of perspectives and backgrounds, and ultimately make substantial progress in eradicating disparities in cancer.